Defining the role of mechanotransduction pathways in activating cardiac fibroblasts to cause fibrosis after myocardial infarction.

PROJECT SUMMARY/ABSTRACT
Fibrosing cardiac diseases cause 25% of deaths in the United States. Fibrosis is a key pathological
hallmark of nearly all cardiac diseases, including hypertensive heart disease, atrial fibrillation, and ischemic heart
disease, which is caused by myocardial infarction (MI). Across these fibrosing cardiac diseases, cardiac
fibroblasts are activated to deposit excessive extracellular matrix that causes organ dysfunction, including
diastolic dysfunction, arrythmias, and heart failure with reduced ejection fraction. Despite the clinical burden of
cardiac fibrosis, especially after MI, the molecular mechanisms driving cardiac fibroblasts to produce excessive
scar tissue are unknown. Uncovering the pathophysiological mechanisms for cardiac fibrosis formation has the
potential to reveal novel drug targets to reduce cardiac fibrosis and improve cardiac function. The Research
Training Plan will investigate the molecular mechanisms for cardiac fibrosis formation after MI. Specifically, this
project will test the hypothesis that thinning of the ventricle wall after MI increases wall stress to activate
mechanotransduction pathways in cardiac fibroblasts to produce scar tissue. To investigate this hypothesis, this
project will combine innovative computational and experimental approaches, such as advanced imaging,
computational modeling, spatial transcriptomics, and animal models. Specific Aim 1 will spatially correlate tissue
fibrosis and wall stress after MI in mice by using 2D histology, 3D whole-organ imaging, and finite element
analysis. Specific Aim 2 will determine the spatial heterogeneity of cardiac fibroblast subpopulations after MI
using publicly available mouse spatial transcriptomics datasets. Specific Aim 3 will functionally test if mechano-
transduction pathways activate cardiac fibroblasts by using an in vitro fibroblast-seeded hydrogel stretch assay
and an in vivo mouse model of MI. In summary, the proposed studies will investigate a possible
pathophysiological mechanism for cardiac fibrosis formation after MI and may provide novel therapeutic targets
to treat patients after MI.
Importantly, through this project, the applicant, John Lu, will gain diverse expertise in cutting-edge
experimental techniques, computational approaches, and scientific reasoning under the mentorship of global
fibrosis expert, Dr. Michael Longaker, and leading cardiovascular biologist, Dr. Kristy Red-Horse. Through his
training activities, John will also develop the professional and clinical skills to direct an independent laboratory
as a future physician-scientist investigator. Furthermore, Stanford University offers an outstanding environment
for innovative and collaborative research, with the necessary infrastructure and core facilities to ensure this
project’s success. In summary, the strong mentoring environment and fellowship training plan will prepare John
to be an independent physician-scientist investigator working at the frontiers of cardiovascular research.

Public health relevance
PROJECT NARRATIVE Myocardial infarction causes tissue fibrosis, organ dysfunction, and heart failure, which leads to 19% of all deaths in the United States. This study will investigate the molecular mechanisms that drive cardiac fibroblasts to deposit excessive scar tissue after myocardial infarction. The results of this study will identify novel targets for therapeutic development to reduce cardiac fibrosis and improve cardiac function after myocardial infarction.